Mechanistic and Therapeutic Studies of GPR124/RECK/WNT7-Regulated Blood-Brain Barrier Function

PROJECT SUMMARY
The cerebrovasculature is a highly specialized vascular bed where cellular and molecular components of the
blood-brain barrier (BBB) stringently regulate entry into the central nervous system (CNS). BBB disruption
occurs in diseases such as stroke, brain tumors and multiple sclerosis and thus improved mechanistic
understanding and directed therapies are urgently needed. Through convergent genetic and biochemical studies,
we and others have defined a GPR124/RECK/WNT7 pathway that is essential for BBB function during
embryogenesis and during pathologic states such as stroke and glioblastoma. In the prior granting period, we
demonstrated that the GPI-anchored membrane protein RECK binds and stabilizes newly secreted WNT7 for
presentation to Frizzled (FZD), the canonical WNT receptor. Remarkably, the GPCR-like 7-pass transmembrane
protein GPR124 synergizes with RECK to potently amplify signaling by WNT7A/WNT7B but not by the other 17
WNTs. While GPR124 function in the BBB has been unequivocally established by in vivo knockout (KO) and in
vitro transfection studies, its molecular mechanism remains an enigma and clinical translation has been elusive.
Here, we pursue both mechanistic and translational investigations into the GPR124/RECK/WNT7
pathway, building upon substantial preliminary data. Aim 1 investigates the hypothesis that GPR124 is crucially
required for coupling of the ligand WNT7 and receptor RECK to the downstream FZD/LRP signaling complex.
We utilize doxycycline-inducible WNT7 expression to initiate WNT7 signaling, surmounting historical difficulties
with WNT7 protein solubility and production, overlaid upon isogenic brain endothelium with and without GPR124
expression, to defining signaling complex dynamics with RECK, FZD and LRP by co-immunoprecipitation and
single molecule resolution live imaging studies. Aim 2 explores the hypothesis that WNT7- and GPR124-
dependent signaling can induce human cerebral angiogenesis and neurovascular unit (NVU) formation,
leveraging our novel adult human brain organoid system that develops extensive vascular networks and
accurately recapitulates NVU cellular interactions within a neuronal context. These adult-derived brain
organoids, developed in the previous granting period, contrast strongly with conventional avascular iPSC-derived
brain organoids. Lastly, Aim 3 investigates the translational potential of the GPR124/RECK/WNT7 pathway
through the hypothesis that agonistic GPR124 ectodomains with and without novel bioengineered FZD4
agonists, administered post-stroke, can improve outcomes in the transient middle cerebral artery occlusion
stroke model. In all, this renewal application leverages substantial progress in the prior granting period to pursue
a comprehensive and multidisciplinary approach to GPR124/RECK/WNT7 mechanism and preclinical
translation, towards the development of BBB-targeted stroke therapeutics.

Public health relevance
PROJECT NARRATIVE A blood-brain barrier (BBB) comprised of multiple different cell types in and around blood vessels shields the brain but is unfortunately damaged in diseases such as stroke, causing bleeding, swelling and entry of potentially injurious substances. Our application examines how the GPR124/RECK/WNT7 pathway ensures normal BBB function and how drugs targeting this pathway can therapeutically stabilize the BBB to improve stroke treatment.